Balancing excitatory and inhibitory LHb signaling underlying stress

PROJECT SUMMARY
Over 40 millions individuals in the United States are impacted by stress related disorders, that are highly
comorbid with mood disorders such as anxiety and depression. Cognitive behavioral therapy and decades of
animal literature has established that reinstating a sense of autonomy or behavioral control over a stressful
experience can buffer many of the psychological and behavioral impacts of stress and reduce the severity of
depressive and anxiety-like behaviors. However, it is not entirely known which neurochemical pathways are
recruited by behavioral control to facilitate or hinder this stress resilience. Understanding how neurochemical
signaling dynamics change following stress (with and without behavioral control) and identifying which
projections are responsible for these changes is a foundational step in developing therapeutics for stress
related disorders. To address this, I will implement a rodent model of stressor controllability to 1) identify how
neurochemical signaling dynamics change following behavioral control, in a brain region highly implicated in
mediating the effects of stress and 2) manipulate neurochemical-specific projections to this region that are
implicated in these changes to identify their involvement in stressor controllability. The goal of the proposed
project is to determine how behavioral control impacts discrete neurochemical signaling specifically between
the lateral habenula (LHb) and the ventral tegmental area (VTA), two interacting brain regions that play causal
roles in both stress and motivated behavior. The successful completion of these aims will address
mechanistically how behavioral control influences LHb neurochemical signaling and test the hypothesis that
the VTA glutamate → LHb pathway contributes to behavioral deficits following stress experience in the
absence of behavioral control.

Public health relevance
PROJECT NARRATIVE Hyperactivity within the lateral habenula (LHb) has been directly linked to the development of anxiety and depressive behavior, following stress experience. However, it is unknown which circuit and neurochemical specific inputs to the LHb are responsible for these changes in habenular activity. The proposed experiments will implement innovative viral imaging and manipulation strategies to establish which circuits and neurotransmitter inputs contribute to LHb dysregulation following stress experience.